Acquisition of disability and chronic morbidity by older Indians following extreme urban coastal flooding events

Older populations in low and middle income countries are often highly dependent on children and other family members for their economic and physical wellbeing. Elders’ housing and households, however, may be adversely impacted by extreme flooding events. Extreme rainfall events have already produced more frequent major coastal urban flooding events in India. Its four largest coastal cities, Mumbai, Kolkata, Chennai and Surat, each experienced extreme flooding events in 2005-2007. Although these extreme flooding events were closely spaced relative to each other, they were each at the time they struck the largest flooding event either of the past three or four decades (Kolkata, Surat) or in recorded meteorological history (Mumbai, Chennai). The 2005-2007 events coincidentally occurred between two successive survey data collection waves of a major panel survey of Indian households, the India Human Development Survey (IHDS). We use pre- and post-flood IHDS panel observation in a decomposition analysis of flood impacts on disability and chronic morbidity acquisition among individuals age 50 and above. Informed by a social-vulnerability theoretical framework, this decomposition analysis uses as predictors both pre-flood socio-demographic and economic characteristics and pre-flood to post-flood housing condition changes, residential mobility, and living arrangement changes. The aims of the study are to estimate India’s urban older population’s: (1) acquisition of disability and chronic morbidity associated with experiencing an extreme coastal-urban flooding event; (2) housing and living arrangement change, kin proximity, and individual and household mobility associated with the flooding events; (3) extent to which changes in housing, living arrangements, and individual and household mobility were mechanisms responsible for acquisition of disability and chronic morbidity; and (4) disparities in adverse impacts on health and family-household stability by pre-flooding individual, family, and household socio-economic and socio-demographic characteristics. The substantive findings and methodological developments of the study are expected to have generalizability for examining threats to elders’ health and wellbeing from extreme coastal flooding events globally.

Public health relevance
This study investigates and develops methods for estimating threats to elders’ health and wellbeing from extreme coastal flooding events in India’s four largest coastal cities. Disability and chronic morbidity are both investigated as outcomes, and family and household structure as mediating processes. The findings will inform public health preparedness in South Asia and elsewhere.